Graduate Training in Biomedical Informatics

DESCRIPTION (provided by applicant): The Stanford Biomedical Informatics (BMI, formerly named Medical Information Sciences) training program continues to offer MS and Ph.D. degrees to students with an intensive training that prepares them for careers in research. The formal course curriculum trains them in a five part curriculum that features (1) core biomedical informatics, (2) domain biology or medicine (3) computer science, (4) probability and statistics, and (5) ethical, legal, and social issues. The curriculum has evolved over 18 years to offer general training in biomedical informatics, appropriate for students whose research subsequently focuses in clinical informatics and/or bioinformatics. Stanford's research milieu also continues to provide excellent opportunities for basic informatics research. Currently, we are in the 17th year as an NLM-supported training program, with 96 trainees. We have had a total of 65 graduates, 40 of whom were NLM-supported at some period. In this proposal, we request continuing support for the training of ten pre-doctoral and six post-doctoral candidates per year, representing a small shift in balance in response to our applicant pool. Most training slots will be used for BMI degree candidates, although we will take advantage of program flexibility to fund post-MD or Ph.D. candidates who are not BMI degree candidates. We are currently receiving more than 120 applications for 4-8 total spots in our program (a subset of which are NLM supported). We propose to continue our successful training program in the next five years, with a refined curriculum (recently generalized to allow informatics training in all areas of biomedicine), an expanded executive committee with greater representation of bioinformatics, an increased presence and leadership in general biomedical computation on campus at Stanford, and a continuing plan for increased affirmative action recruitment of women and minority students. The BMI program will therefore continue to produce leaders in academic and industrial biomedical informatics, and will continue to respond to the changing landscape of biomedical research in an information age.